Strategies for Preventing Underage Drinking and Other Substance Use in Native American Tribal Communities

? DESCRIPTION (provided by applicant): The goal of this proposed research program is to implement and evaluate complementary interventions designed to address underage alcohol and other substance use and abuse among Native American youth residing in and around nine contiguous Indian reservations in rural San Diego County. The application directly builds upon the successful collaboration between Indian Health Council, Inc., Prevention Research Center, and The Scripps Research Institute, with pilot and demonstration studies focusing on reducing the supply of and demand for alcohol by Native American youth through a series of environmental and individual interventions that have shown efficacy and have gained acceptability in the communities served by the clinics. The overall goal of the present proposal will be accomplished through two complementary efforts, one aimed at the community (supply) level and the other at the individual (demand) level. The community-based environmental prevention program will focus on (a) reducing underage access to alcohol and tobacco through a reward and reminder program for off-premise retail clerks and (b) tailoring, implementing and evaluating a community mobilization and awareness intervention aimed at reducing the social availability of alcohol, tobacco, and other drugs from adults, including extended family members. These community-level programs will be complemented with interventions at the individual level; including implementing and evaluating a culturally tailored motivational interviewing brief intervention to reduce demand for alcohol and other drugs for American Indian youth 13-20 years of age who are substance users. These individual level interventions will be culturally tailored to appropriately address substance use by Native American youths from the nine tribes. We will evaluate the effectiveness of these programs by analyzing multiple data sources: (a) outcome data from the Motivational Interviewing trial among tribal youth, (b) data from school and community youth surveys on youths' self-reported substance use and related problems including driving under the influence, (c) emergency room discharge data, and (d) law enforcement data on alcohol/drug-related events. For the purposes of evaluation, these data from the Indian Health Council catchment area will be compared to data from surveys of both non-Native and Native American youth who were not involved in the intervention activities. The research will continue to build cohorts of expert Native American research staff and student interns for actualizing the proposed research and interventions. The team will create intervention workbooks for standardized application of the intervention techniques in other Native American communities.

Public health relevance
PUBLIC HEALTH RELEVANCE: Building upon successful collaborative capacity building efforts, the proposed 5 year study will implement and evaluate interventions designed to address underage alcohol, tobacco, and other drug use and misuse (and related problems such as intoxicated driving) in and around 9 rural Southern California Indian reservations. The proposed interventions integrate community based environmental formal and social availability reduction programs with individual screening and motivational interviewing in a culturally appropriate way. This project offers significant potential reductions in immediate as well as long-term harm resulting from underage alcohol, tobacco and other drug use and misuse among rural Native Americans.